CATALYTIC PLATFORMS USING AROMATIC IONS AND OTHER CHARGED SPECIES

Project Summary. Catalysis has long been a potent force for advancing biomedical research by enabling the
construction of biologically important molecules with ever-increasing speed, efficiency, and versatility. One of
the most potent driving forces for progress in the area of catalysis has been the discovery of new catalytic
platforms and concepts. The proposed research program is broadly focused on advancing the area of catalysis
through the development of novel catalytic platforms, concepts, and methods. In particular, we have developed
two generic catalytic strategies with broad applicability over a wide array of reaction types. In the first program,
we have helped to pioneer the area of electrophotocatalysis, which combines the power of light and electrical
energy within a single catalyst to promote challenging chemical reactions. Especially, we have introduced
trisaminocyclopropenium (TAC) ions as a novel class of electrophotocatalyst; these catalysts have proven to
be useful for a number of transformations, including C–H bond functionalizations and olefin derivatizations. The
current application seeks to leverage electrophotocatalysis to realize other challenging, unprecedented
reactions, especially those requiring very high redox potentials or involving multiple redox events. In the
second program, we have pioneered the area of catalytic carbonyl-olefin metathesis, using hydrazine catalysis.
This foundational capability enables a wide range of potentially advantageous synthetic methods. The current
application seeks to make major advances to this program by designing highly reactive, next-generation
catalysts that greatly expand the scope of substrates that can be engaged. We also aim to apply this mode of
catalysis to useful new chemical methods, and to develop related catalytic platforms using these general
principles. These and other investigations into the use of novel ideas in catalysis will continue to serve as a
stimulus for advancements in chemical synthesis.

Public health relevance
One of the most significant impediments to the discovery of new medicinal agents is the inability to assemble complex molecules rapidly, efficiently, and with predictable outcomes. This proposal aims to address a number of major technological gaps in the field of organic synthesis through innovations in catalysis, which will greatly accelerate the preparation of medicinal lead structures.